Macrophage-targeting Nanoplatforms as Immunotherapy against Pulmonary Infections

PROJECT SUMMARY
New strategies to combat pneumonia caused by different pathogens are urgently needed. Inflammatory
macrophages play an essential role in clearing bacteria, fungi, and viruses during infections; however,
hyperinflammatory responses mediated by these cells can cause severe side effects, including death.
Immunotherapy that modulates macrophage polarization has shown promise in suppressing hyperinflammatory
responses while retaining the capability of macrophages to clear pathogens. To achieve successful
immunotherapy with RNA therapeutics, the following obstacles must be overcome: (1) rapid clearance of RNA
therapeutics by RNase in tissues; (2) poor cellular uptake of free RNA therapeutics; and (3) loss of RNA
therapeutics to non-infected tissues and potential off-target side effects. We previously discovered and
successfully transitioned to industry two nanotherapeutic systems that addressed these limitations for bacterial
infections. The elements of the nanosystems relevant to the present proposal are: high loading capacity for RNA
therapeutics; an ability to protect the RNA payload from degradation in vivo; and highly selective targeting of the
macrophages via pendant peptides. The proposed project hypothesizes that this approach may be generally
applicable across a spectrum of pathogens, and it aims to investigate treatment of viral and fungal pulmonary
infections. To address these goals, a deeper understanding of macrophage function and nanoparticle
interactions is needed, particularly in the context of pathogenic infections. Through three Specific Aims, we
propose to optimize and then evaluate three major nanoplatform-based systems that have shown promise for
nucleic acid delivery, and investigate the in vivo biological interactions of the targeted nanoplatforms to obtain
deeper understanding of macrophage polarization in combating pulmonary infections:
(1) Develop a targeting strategy for macrophage homing in infected lungs. We hypothesize designs that will allow
the nanoparticle to reach the infected regions of the lungs while preserving the potency of the RNAi therapeutic,
either by i.v. or by direct pulmonary delivery of nanoplatforms. This Aim will focus on screening for new peptides
that target macrophages in lung infection models, using the existing macrophage-targeting peptide CRV as a
benchmark. We will focus on well-established mouse models of pneumonia induced by carbapenem-resistant
K. pneumoniae, A. fumigatus, and influenza A.
(2) Develop, evaluate, and then downselect from three broad classes of nanoplatforms (i.e., lipid nanoparticles,
tandem peptide nanoparticles, and fusogenic porous silicon nanoparticles) to load RNA therapeutics. These
nanoplatforms will be targeted to macrophages in the infected lungs using peptides from Aim 1. Cytotoxicity,
gene knockdown efficiency, and macrophage polarization will be evaluated in vitro. Pharmacokinetics including
macrophage targeting and tissue distribution will be studied in vivo.
(3) Evaluate leading candidate(s) from Aim 2 for therapeutic performance in vivo through intranasal or nebulizing
administration. The goal of this Aim is to evaluate biosafety and therapeutic efficacy (i.e., pathogen burden
clearance, tissue recovery, and improved survival).
The significance of this project is that it will yield tools to actively target macrophages at infected lungs and it will
identify the essential design rules for nanoplatforms that can provide immunotherapy to combat a wide range of
pulmonary infections.

Public health relevance
PROJECT NARRATIVE This project aims to develop a targeting strategy involving macrophage-targeting peptide ligands for targeted delivery of nanoplatforms that carry RNA therapeutics. Deploying existing or newly discovered peptides and deploying design rules from three broad classes of nanoparticles (lipid-based, tandem peptide-based, and mesoporous silicon-based) and it will identify an optimal nanoplatform to treat in vivo carbapenem-resistant Klebsiella pneumoniae (CRKP), Aspergillus fumigatus, and influenza A pneumonia.